UAB Childhood Cystic Kidney Disease Core Center (UAB-CCKDCC) - Administrative Core

ABSTRACT (ADMINISTRATIVE CORE)
The primary mission of the UAB-Childhood Cystic Kidney Disease Core Center (UAB-CCKDCC) is to work
with the PKD Consortium, under the guidance of the U24 Central Coordinating Site (U24-CCS) and
NIDDK, to eliminate obstacles in cystic kidney disease research that are slowing progress toward
the development of improved and innovative treatment strategies for cystic kidney disorders. The UAB-
CCKDCC has assembled a multidisciplinary team of researchers, each with strong research programs, who will
direct four tightly integrated resource and service-oriented Cores along with an Administrative Core. The
overarching and collective mission of these Cores is to support, accelerate, and expand basic and translational
research activities being performed by PKD Consortium members. The Center will focus on the development of
resources to analyze cilio-cystic disease protein function, localization, and interactions and to assess how
defects in these functions contribute to the pathogenic mechanisms involved in cyst initiation and progression.
The Center will complete its mission through providing ready access to clinical data and biomaterial from CCKD
patients, through the development and distribution of patient-relevant cell and animal models of CCKD, and
through the development of methodology to utilize these models to ascertain the efficacy of candidate therapies
to slow disease progression using a standardized, cost-effective, and longitudinal imaging and analysis
strategies. The services and resources being made available by the Center along with the integration of our
Cores will expand research activities beyond that capable in most individual laboratories. It will accelerate the
pace of research into causes and possible cures of cystic kidney diseases by providing for high quality, robust,
and reproducible outcomes. These are critically needed to prioritize drugs for future clinical trials to halt PKD and
other cystic kidney disorders.
Essential to fulfilling the mission of the UAB-CKDCC is the Administrative Core. The Administrative Core will
provide for the Center’s overall structure to make sure that each of the Cores is working toward the common
goal of developing better treatments options for CCKD. The Administrative Core will be responsible for financial
and scientific oversight, coordinate efforts to ensure that each Core’s activities are aligned with those of the other
U54-PKD Centers (RTCC), and that the focus of each Core reflects the priorities established by the U24-CCS
and NIDDK. The Administrative Core will establish benchmarks and ensure they are achieved, that Center
resources and services being provided to the PKD Consortium, that they are authenticated, robust, and are
delivered in a timely manner, and are not delayed by material transfer agreements or other legal hurdles.